Environmental Health Informatics Core

ENVIRONMENTAL HEALTH INFORMATICS CORE (EHIC): ABSTRACT
The Environmental Health Informatics Core (EHIC) supports CEET investigators using diverse
expertise in environmental health informatics, a mission consistent with the existing NIEHS
Strategic Plan “To Promote Translation from Data to Knowledge to Action” and that embraces the
new area of NIEHS scientific focus in computational biology and data science. Our vision is to
provide agile support to CEET investigators on the use of both routine and innovative
computational methods to gain insights from large and complex environmental health datasets.
In addition, we develop novel analytical strategies when existing approaches are not adequate,
and we create efficient workflows to maximize the number of investigators we are able to help.
Environmental health scientists are faced with an avalanche of big data unique to this discipline.
Unlike other disciplines which may generate traditional “omics” data there is an urgent need to
analyze exposomics data (satellite, biosensor, wearable and biomarker data), and relate these
data to Electronic Health Records (EHRs), use chemoinformatics to predict the toxicity of
unknowns, and extract public health information for epidemiologic studies. We provide
bioinformatics, biomedical informatics, chemoinformatics and public health informatics services
to accelerate research in these areas. Our bioinformatics services include analysis of many types
of omics data, including genomic, transcriptomic, epigenomic, proteomic, lipidomic and
metabolomic, as well as their integration using multiomics methods. Our biomedical informatics
services include extraction and analysis of data from EHRs, biobanks, and disease registries;
digital phenotyping; and use of ontologies to improve interoperability of datasets and their use in
large scale research efforts. Our chemoinformatics services include development and use of a
graph-knowledge database called ComptoxAI that provides insights into predictive toxicology,
adverse outcome pathways, and quantitative structure-activity relationships. Our public health
informatics services include analysis of geospatially distributed environmental data, and data
collected with pollution sensors, biosensors, and wearable devices. Our services are underpinned
by analytical tools that include data science, machine learning, and artificial intelligence. We work
closely with the Translational Research Support Core (TRSC) and Biomolecular Mass
Spectrometry Core (BMSC) to provide support to the four CEET thematic areas and the crosscutting
themes of exposomics and the effects of extreme weather on health.